Low-cost Production of a Vaccine for Lyme Disease in Maize

PROJECT SUMMARY/ABSTRACT
In keeping with the NIH’s stated priority for the development of vaccines to bacterial zoonoses, our goal is to
develop an effective and conveniently delivered vaccine to protect against the spirochaete, Borrelia burgdorferi,
the causative agent of Lyme disease. The bacterium is vectored by infected Ixodes species ticks between
humans and mammalian reservoirs.
Our chosen antigen candidate is OspA, a surface protein which presents as the spirochaete transits between
the arthropod vector and the mammalian host. Vaccination with this antigen allows protective antibodies to
encounter the spirochaete while still inside the tick as it engorges with a blood meal, and has been shown to be
effective as a transmission blocking vaccine.
In order to develop adequate amounts of antigen for an effective and adequate immune response, we have
established a proprietorial expression system using recombinant maize. An additional advantage of maize
expression is that vaccine antigens can be directly administered through the oral route rather than purified for
injection. In this proposal, our goal is to produce large amounts of OspA antigen candidate in maize, orally
administer the antigen to mice in feed formulated from recombinant maize flour, and demonstrate that the antigen
elicits a protective immune response against challenge.

Public health relevance
PROJECT NARRATIVE Successful completion of this project will lead to the scalable production of oral vaccines that protect against the transmission of the bacterium that causes Lyme disease from the vector to a mammalian host. An efficacious and orally administered vaccine will meet the dual need for an immunization in humans as well as in a variety of animal reservoir hosts by providing the vaccine encapsulated in maize seed. Our previous work has established the effectiveness of vaccine production in maize, and our partnership with experts in Lyme disease transmission and vaccine production will provide the synergy to develop an effective vaccine delivered through a novel route.